Administrative Core

The Penn Center for Musculoskeletal Disorders (PCMD) at the University of Pennsylvania will enhance the
research productivity of, and provide critical services, resources and programs to, established and new
investigators who represent our Center membership. The overall goal of this Center is to promote cooperative
interactions among investigators, accelerate and enrich the effectiveness and efficiency of ongoing research,
foster new collaborations and new research, and ultimately, translate our research efforts into better and new
therapies for musculoskeletal disorders. This will be done through providing critical research infrastructure,
state-of-the-art research resources, study design guidance, and intellectual expertise to musculoskeletal
investigators. Importantly, the Center serves as a local and regional resource to expand the musculoskeletal
community and recruit new investigators to the field. We have chosen to continue the theme of
“Musculoskeletal Tissue Injury and Repair” for the Center. The Administrative Core coordinates all of the
necessary leadership, organizational and supervisory activities of the Center. Importantly, the Administrative
Core is on the 3rd floor of Stemmler Hall, the same floor/building as the three Resource Cores, defining a clear
home for the PCMD overall.
The Specific Aims of this Administrative Core are to: Aim 1: Coordinate, integrate, communicate, and
monitor the Center components and activities; Aim 2: Advise the Center Director regarding the activities of the
Center; Aim 3: Administer the Pilot and Feasibility Grant Program and its associated funding and reporting;
Aim 4: Implement an Enrichment Program; and Aim 5: Provide a Resource Sharing Plan. A well organized
Administrative Core is essential to accomplish our Aims, and maximize research activity, efficiency, and
productivity of the more than 200 Center faculty members. One of the great strengths of our Center is its
inclusive approach with a broad spectrum of activities and interactions. Further, it has evolved into a regional
technical and intellectual hub for the broader Philadelphia musculoskeletal research community and beyond,
attracting and providing resources to faculty from more than 15 other institutions in our region. One more
intangible feature to our Administrative Core and Center that should not be overlooked is our unique voice
representing the musculoskeletal research community at Penn. The University’s biomedical research
community in general is very large and engaged in multiple disciplines and fields. As a result, this P30
supported Center performs an essential role by highlighting the importance, broad relevance, and excitement
of musculoskeletal research across campus, and provides our members a strong voice and presence across
the University. Having a clear, consistent, and strong voice for musculoskeletal researchers has served, and
will continue to serve, our collective and individual research goals. In these ways, the Center - with critical
financial support from the P30 - is indispensable for our local and regional research community.

Public health relevance
The Penn Center for Musculoskeletal Disorders (PCMD) at the University of Pennsylvania will enhance the research productivity of, and provide critical services, resources and programs to, established and new investigators who represent our Center membership. The overall goal of this Center is to promote cooperative interactions among investigators, accelerate and enrich the effectiveness and efficiency of ongoing research, foster new collaborations and new research, and ultimately, translate our research efforts into better and new therapies for musculoskeletal disorders. This will be done through providing critical research infrastructure, state-of-the-art research resources, study design guidance, and intellectual expertise to musculoskeletal investigators.